Society of Toxicology Annual Meetings

Project Abstract Summary PAR?14?237 FDA Scientific Conference Grant Program (13/U13) The Society of Toxicology Annual Meeting is the largest toxicology meeting and exhibition in the world, attracting more than 6,500 scientists from industry, academia, and government from th more than 50 countries around the globe. The 54 SOT Annual Meeting will be held at the San Diego Convention Center (fully compliant with the accessibility guidelines of the Americans with Disability Act) in San Diego, California, from March 22–26, 2015. The annual meeting program includes plenary and other special lectures, symposia, workshops, roundtable discussions, and platform and poster sessions of cutting?edge research. The meeting includes 13 continuing education courses from basic to advanced. In addition, the Society presents annual awards to recognize outstanding achievements in toxicology. Themes for the 2015 SOT Annual Meeting include Advancing Clinical and Translational Toxicology, Epigenomic Influences in Toxicological Responses, Safety Assessment Approaches for Product Development, and Strategies for Exposure and Risk Assessments. Moreover, SOT attendees can take advantage of the ToxExpo, which is the world’s largest exposition of its kind, offering comprehensive product information and cutting?edge technology. There will be a multi?day program for undergraduates and their mentors who are under-represented in the sciences.

Public health relevance
Project Narrative PAR-14-237: FDA Scientific Conference Grant Program (R13/U13) The Society of Toxicology (SOT) is a global organization with more than 7,700 members. The SOT Annual Meetings helps to forward the vision of the Society of “creating a safer and healthier world by advancing the science of toxicology.” The SOT Annual Meeting provides a most complete and in-depth coverage of toxicology, focusing on research on the mechanisms of disease that can lead to health protection and disease prevention for humans and the environment. 1